Characterizing the Conformations and Neurotoxic Species of Huntingtin

The exon-1 of mutant huntingtin protein (mHTTex1) accumulates in the brains of Huntington’s disease (HD)
patients and is implicated in neurodegeneration. The intrinsically disordered mHTTex1 misfolds into a
heterogeneous mixture of assemblies, however, the pathogenic conformers are not well characterized. The
major limiting factors have been the lack of methods to assemble ultrapure mHTTex1 structures, molecular
tools to identify them and models to investigate their neurotoxicity. Towards this end, we have developed
protocols to assemble distinct oligomers, protofibrils and fibrils of mHTTex1 and have generated libraries of
monoclonal antibodies (mAbs) to defined structures. We plan to characterize the binding of representative
mAbs to conformations in various assemblies using biophysical and biochemical methods, explore whether the
interaction of each mAb with its epitope affects the misfolding, seeding and aggregation in vitro, and examine
the structures of mHTTex1 species upon binding to selected mAbs (aim 1). We have further developed a
diagnostic platform to study the entry of structurally known mHTTex1 species into human neurons and their
aggregation into neurotoxic assemblies. With this model, we plan to identify and characterize the
neuroinvasive/neurotoxic species of mHTTex1, map their pathogenic conformations and determine their
structures with biophysical methods including Cryo-EM. Moreover, we plan to discover the neuronal receptors,
which participate in the entry of mHTTex1 and identify the interacting proteins, which are incorporated in the
neurotoxic aggregates. In addition, we plan to examine for the presence of neuroinvasive mHTT species in the
brains of HD patients and in human neuronal and mouse models of HD to validate the physiological relevance
of the in vitro-assembled structures and any links to disease severity. These experiments may for the first time
identify the structures of neurotoxic mHTTex1 at high resolution, a novel pathway for their production, and may
provide targets for therapy development (aim 2). In aim 3, we will investigate the role extracellular mHTT in
disease in the CNS of HD mice. In one set of experiments, we plan to inject neuroinvasive species of
mHTTex1 into the brains of asymptomatic R6/2Q51 HD mice (express human mHTTex1 with 51Qs) and
investigate their ability to enter neurons, trigger assembly formation and accelerate disease progression.
Moreover, we will determine whether blocking any of the pathogenic conformations of mHTTex1 by AAV-
mediated delivery of recombinant antibodies, which are secreted in the CNS, inhibits the entry, amplification
and neurotoxicity of the injected species. Finally, given that mHTT is present in the CSF and plasma of HD
patients and mouse models, we plan to investigate the therapeutic impacts of secreted recombinant antibodies
on the accumulation of pathogenic mHTT assemblies and progression of HD-like pathology in the Q140 HD
mice expressing full-length mHTT. These studies will fill some of the knowledge gaps on the role of
extracellular mHTT in the pathogenesis of HD and may provide therapeutic targets and reagents.

Public health relevance
Using a collection of novel monoclonal antibodies raised to structurally-defined species of mutant huntingtin exon1 (mHTTex1), we will characterize the structure and biochemical properties of various mHTTex1 assemblies, map the conformations influencing misfolding, seeding, and oligomerization in vitro, identify and characterize neuroinvasive species in human neurons and determine whether they trigger pathology in mouse models of HD. Moreover, we will examine whether any of the recombinant conformation-specific antibodies secreted in the CNS of HD mice inhibit the amplification of mHTT assemblies, and further validate their therapeutic properties. These studies will fill some of the knowledge gaps in the pathogenesis of HD, introduce novel therapeutic targets, and a collection of well-characterized antibodies and their recombinant versions for diagnostic and therapeutic applications.